Defining age-associated alterations in oral squamous cell carcinoma

Abstract
Head and neck cancer squamous cell carcinomas (HNSCC) are the seventh most common cancers globally and
are associated with poor survival rates. Pharmacological treatments for HNSCC remain largely ineffective and
improving drug therapies requires the identification of novel factors that modulate not just the tumor but also the
surrounding permissive oral microenvironment. One such novel factor may be the aging of the tissue. While
older age is associated with worse five-year survival for HNSCC, almost all preclinical cancer model studies
focus on outcomes in young animals. This discordance between preclinical adolescent in vivo models and largely
elderly target patient populations may underlie the poor efficacy of treatment for HNSCC. The goal of this
proposal is to define molecular events associated with HNSCC progression in aged tissues with the hope to
uncover targetable mechanisms that may offer new therapeutic avenues. To test the influence of age on HNSCC,
we optimized syngeneic orthotopic tongue xenograft models of HNSCC. We observed more rapid tumor growth
in old animals, with tumors exhibiting an age-associated, immune evasive, transcriptionally-distinct tumor cell
states as well as an age-associated collagen-secreting/modifying fibroblast population. A critical factor that may
be involved in these age-associated alterations is the transcriptional regulator Yes-associated protein (YAP), a
Hippo signaling effector that has a pro-tumorigenic role in HNSCC, including modulating the expression of genes
that track with disease progression and treatment resistance. YAP mediates transcriptional changes that
promote aggressive cell behavior and immune evasion, dynamics that may preferentially promote disease
severity in older patients. Furthermore, the transcriptome of old animals revealed distinct elevation of the Runt-
related transcription factor 1 (RUNX1) in aged oral tumor cells. RUNX1 is a YAP DNA-binding partner and has
been implicated as a biomarker of worse HNSCC survival. We hypothesize that the aged oral tissue
microenvironment is permissive to tumorigenesis in part due to extracellular matrix dynamics that drive elevated
YAP and RUNX1 activity. In Aim 1, we will examine YAP-depleted and RUNX1-depleted tumor cell behavior in
old and young mice using genomic, epigenomic and transcriptomic analyses in our syngeneic orthotopic
xenograft models. Data collected from this aim will offer a comprehensive comparison of the role of YAP and
RUNX1 on the mediating age-associated alterations observed in HNSCC. In Aim 2, we will define age-associated
changes to lymphocytic and myeloid immune populations in the aged oral tumor niche and test the impact of
matrix stiffness on conferring these age-associated alterations to immune and tumor cell populations in our
syngeneic xenograft models. Data collected from this aim will provide a comprehensive assessment of age-
associated immune and mechanical tissue targets for potential future therapeutics in HNSCC. In addition, our
proposed plan provides an opportunity for diverse training in molecular, cellular and genetic biology, combined
with bioinformatics and translational medicine, honing the skills required for success as a physician-scientist.

Public health relevance
Project Narrative Head and neck squamous cell carcinomas (HNSCCs) confer significant morbidity and mortality that associate with older age, yet preclinical models predominately focus on outcomes in young animals, possibly underlying the poor efficacy of current pharmacological treatments. We propose to test how age impacts the cellular, epigenetic, and transcriptional behavior of a syngeneic orthotopic xenograft model of HNSCC. Our study will provide a comprehensive characterization of tumors in different aged niches, providing insight to age- associated mechanisms of pro-tumorigenic phenotypes that may be targeted for the future development of treatments to improve clinical outcomes for patients.